Trigeminal Afferents Regulation of Apical Periodontitis Development

Project Summary
Apical periodontitis (AP) is a highly prevalent and debilitating pathological condition marked by
bone resorption and pain as result of dental infections. Many elegant studies have revealed the
functions of immune cells and inflammatory mediators in AP. Despite AP being densely
innervated by trigeminal ganglia (TG) fibers, the participation of these afferents in this disease
process is largely unknown. Our preliminary data demonstrate that TG neurons regulate AP
lesion development. The objective of this proposal is to understand how TG fibers control AP
development, which remains a large gap in knowledge. We, for the first time, propose to
investigate neurons/non-neuronal cell interaction in control of AP development for each of four
major subclasses of TG neurons. This is novel and critically important strategy in approaching
research on regulation of AP development by sensory neurons, since each neuronal sub-class
has distinct function and biochemical make up, including unique sets of receptors, ion channels
and neuropeptides. Hence, it is possible that regulatory potential of TG neuronal subsets could
dramatically vary; and even produce opposite effects on osteoclasts and osteoblasts. So
according to literature and preliminary experiments, we designed a novel strategy on study AP
development by TG neurons. Our central hypothesis is that in response to infection certain
subclasses of TG afferents inhibit bone resorption in apical periodontitis via the regulation of
osteoclastic and osteoblastic activities. This hypothesis will be tested in: Aim 1 examining role
of different subclasses of TG afferents in inhibiting bone resorption and immunological
responses in a murine model of infection-induced AP; Aim 2 defining involvement of different
subclasses of TG neurons on regulation of osteoclastic and osteoblastic functions; and Aim 3
defining and identifying the released soluble factor(s) from different subclasses of TG neurons
and their contribution to modulation of osteoclast and osteoblast functions. We believe that
knowledge generated by this application will have a substantial positive impact from both
scientific and clinical perspectives. Scientifically, this is the principally novel approach in
investigation of AP using subclass-specific TG mouse lines. Moreover, the generated new
insight into interactions between neurons and DCS remodeling will open pathways for further
scientific advancement. Clinically, identification of neuronal regulatory mechanisms could offer
novel strategies and, importantly, targets for developing anti-AP therapeutics.

Public health relevance
Project Narrative Bone loss due to dental infections is a significant problem affecting millions of patients in the Unites States alone. Importantly, the mechanisms of this pathologic process are incompletely understood, and this impedes development of novel therapies. We propose a novel mechanism of trigeminal ganglia sensory neuron-mediated regulation of bone remodeling that will provide knowledge for future research at developing drugs to be used as adjuncts in dental treatment. Specifically, the current application proposes to study the function of distinct subclasses of trigeminal afferents in regulating bone resorption in apical periodontitis.